New York Community-Hospital-Academic Maternal Health Partnerships (NY-CHAMP)

OVERALL: The broad goal of the New York Community-Hospital-Academic Maternal Health Partnerships (NY- CHAMP) is to upend the maternal healthcare ecosystem in New York City (NYC) and New York State (NYS) by establishing a sustainable, highly collaborative infrastructure for community-centered maternal health science. We have carefully co-designed, with our partners, a research, training, and community engagement agenda that will 1) identify and address the comorbid biologic and psychologic pathways linking adverse social determinants of health (SDoH) to SMM and MM; and 2) co-create and implement scalable multi-level strategies to inform systems and policy change in our city and region. NY- CHAMP is set against the compelling backdrop of persistently high rates in SMM/MM across urban and rural parts of our state alike, despite a multitude of healthcare facilities and resources. More effective partnerships that break down silos and leverage the knowledge and strengths of our communities, hospitals, academic institutions, and government agencies are essential to assuring access to patient-centered care and addressing SMM/MM. We convene Columbia University and Weill Cornell Medicine, leading community organizations (Caribbean Women’s Health Association, Northern Manhattan Perinatal Partnership, and The Bridge), and a broad coalition of multisector actors to address 2 synergistic Overall Aims. In Aim 1, we will implement a unified, community-driven research program that will: Project 1) Conduct a Type 1 Hybrid Effectiveness-Implementation Trial of a novel doula-delivered cognitive behavioral therapy program holistically designed to address CV, MH, and SDoH outcomes during postpartum; build trauma-informed and empowerment-based service delivery models; and strengthen hospital-community care linkages. Project 2) Apply mixed methods to evaluate the effects of and excess costs attributable to social risk factors and SMM/MM and the mitigating effects of two policy interventions for reducing maternal health disparities. In Aim 2, we will establish the Community Engagement Core (CEC) to serve as an enduring platform for iterative community input, co-design processes, and research dissemination, and capacity building. In Aim 3, we will establish the Career Development and Training Core (CDTC) to transform the maternal health research culture and pipeline of early-stage investigators expertly trained in community partnerships and interdisciplinarity. Our vision is perfectly aligned with the priorities, needs, and assets of our communities and with the NIH’s IMPROVE initiative. Ultimately, NY-CHAMP will alter the underlying drivers of SMM/MM in NYC and NYS and shift the scientific paradigm for excellence in maternal health research.

Public health relevance
PROJECT NARRATIVE The broad goal of the New York Community-Hospital-Academic Maternal Health Partnerships (NY- CHAMP) is to launch a novel community-centered research, training, and engagement program that will identify and address the comorbid biologic and psychologic pathways linking social determinants of health to severe maternal morbidity and mortality (SMM/MM); and with our partners, co-design scalable multi-level strategies to reduce SMM/MM in New York City and State. NY-CHAMP brings together Columbia University, Weill Cornell Medicine, leading community organizations, and a broad coalition of community, hospital, academic, and government partners in a highly collaborative, paradigm-shifting model for excellence in maternal health research.